Investigating dopamine's role in olfactory navigation

Project Summary
Olfaction is the primary sensory modality that many animals use to navigate. However, navigating through the
chemical world is inherently challenging due to the complexity of odor plumes, which can vary in both composition
and concentration. Tracking a plume to its source therefore requires the integration of complex sensory cues
with continuous spatial decision-making, posing a distinct challenge to the flexibility of the nervous system.
Dopamine has been extensively studied as a neuromodulator that confers flexibility to nervous systems, yet the
anatomical heterogeneity and genetic inaccessibility of mammalian dopaminergic systems have precluded a
detailed understanding of dopamine’s role at the molecular and circuit level. In comparison, the simple neural
architecture and genetic tractability of Drosophila melanogaster provide an exceptional model to study the role
of dopaminergic modulation during flexible, naturalistic behaviors like olfactory navigation, as flies robustly track
odor plumes using neural circuits that are both genetically accessible and comprehensively mapped at synaptic
resolution. In preliminary data, I demonstrated that dopamine neurons in the Drosophila mushroom body, an
associative brain center essential for olfactory learning and memory, are continuously engaged during olfactory
navigation and can rapidly and bidirectionally bias a fly’s navigational strategy. I also showed that Kenyon cells,
the post-synaptic targets of dopaminergic modulation whose activity is required for associative plasticity in the
mushroom body, are also required for sustained olfactory pursuit. Using in vivo two-photon imaging, I showed
that the strength of signaling from mushroom body output neurons can be rapidly modulated as flies navigate
within a virtual olfactory landscape. These results support the hypothesis that the same dopaminergic plasticity
mechanisms underlying associative learning are also continuously engaged to regulate and dynamically shape
ongoing olfactory navigation. In Aim 1, I will leverage in vivo two-photon imaging and optogenetic perturbations
of neural activity to define both correlational and causal relationships between the activity of dopamine neurons
and their downstream mushroom body output neurons. In Aim 2, I will use a targeted genetic knockdown strategy
in combination with optogenetics to identify the dopamine receptor signaling pathways mediating dopaminergic
modulation during olfactory navigation. Together, these studies will provide an updated framework for
understanding how dopamine dynamics can flexibly guide naturalistic behaviors like navigation, in circuits with
fully characterized cell types and synaptic connections.

Public health relevance
Project Narrative The proposed research aims to investigate how dopamine signaling acts to dynamically shape olfactory navigation using Drosophila as a powerful model, given that flies robustly track odor plumes using neural circuits that are genetically accessible and comprehensively mapped at synaptic resolution. Dysfunctional dopaminergic signaling is associated with a wide range of neuropsychiatric conditions, including schizophrenia and Parkinson’s disease. Understanding how dopamine functions to continuously modulate the activity of its downstream targets will provide mechanistic insight into how brains balance the competing demands of acute decision-making and learning that instructs future behaviors.